Bitter and sweet taste receptor physiology in airway ciliated cells

PROJECT SUMMARY T2R bitter taste receptors in airway cell cilia detect bacterial acyl-homoserine lactones and quinolones. Activation of these T2Rs increases nitric oxide (NO) production to increase ciliary beating and kill bacteria. T2Rs thus play an important role in airway innate immunity. Polymorphisms that reduce the function of cilia T2Rs correlate with increased gram negative upper respiratory infections, susceptibility to chronic rhinosinusitis, and worse surgical outcomes after sinus surgery. Targeting T2Rs or enhancing their activity may be a complementary or alternative to antibiotics. Boosting endogenous T2R-mediated immunity in the airway or other organs may be a useful anti-pathogen strategy in the face of the increasing prevalence of antibiotic-resistant “superbugs.” NO can be bactericidal and also can inactivate viruses. T2Rs also activate NO production in other tissues and immune cells like macrophages, where T2R to NO signaling regulates phagocytosis. T2Rs activate the endothelial (e) form of nitric oxide synthase (eNOS) in both primary airway cells and macrophages. This pathway appears to be a hallmark of T2R signaling in many cell types and regulates multiple physiological processes. Understanding how T2Rs signal to eNOS is critical for understanding extraoral taste receptor signaling in many tissues. We hypothesize that T2R to eNOS signaling requires phosphorylation of eNOS by kinases activated downstream of the T2Rs. Kinase pathways activated by T2Rs are very unexplored compared with many other GPCRs. We also hypothesize that this kinase phosphorylation is enhanced by HSP90, an important cellular chaperone protein involved in NOS function as well as some GPCR signaling. In this proposal, we will investigate T2R-mediated phosphorylation of NOS and consequences for NO production in primary nasal epithelial cells isolated from residual surgical material and grown at air-liquid interface (Aim 1). We will use live cell imaging of NO production and biochemistry combined with well-characterized pharmacological inhibitors of kinase pathways known to activate eNOS. We will also use well characterized pharmacological HSP90 inhibitors to characterize if HSP90 regulates T2R or eNOS localization to airway cilia or function (calcium signaling or NO production).

Public health relevance
PROJECT NARRATIVE Bacteria in the airway can activate bitter taste receptors (known as T2Rs) expressed in airway cell cilia, which activates the airway cells to produce bactericidal nitric oxide. Activating or enhancing this pathway may be beneficial for people with chronic respiratory infections, as observed in the disease chronic rhinosinusitis. In this proposal, we will identify the mechanisms by which T2Rs activate nitric oxide production so that we can better understand how to target this pathway to treat respiratory infections and likely other types of infections.